PROTECT - Harnessing PROTEin degradation for Advanced Childhood Tumors

eRA ASSIST for NCI – PROTECT
Title: PROTECT – Harnessing PROTEin degradation for Advanced Childhood
Tumors
Abstract:
Background
Survival rates for children with solid tumors, including brain, have largely
plateaued over the past three decades making them the most common cause of
disease-related mortality in this age group. After decades of optimizing
chemotherapy and radiotherapy protocols, higher cure rates for childhood solid
tumors will no longer be achieved by “more of the same.” Rather, cures will
require innovative interventions that specifically target the unique biology of these
tumors, which are often driven by oncogenic fusions and other pediatric-specific
oncoproteins historically considered difficult drug targets. With advances in
targeted protein degradation and chemical interventions to inhibit protein-protein
interactions, it has recently become tractable to target these proteins previously
thought to be “undruggable”. Moreover, unbiased functional screening approaches,
such as CRISPR-Cas9, have revealed new pediatric cancer synthetic lethal
liabilities in need of targeted inhibitors.
Aims
We aim to lead the transformation of delivering such specific treatments to our
young patients harnessing the power of a highly interdisciplinary and collaborative
team of world-leading experts in pediatric oncology, targeted protein degradation,
high-throughput chemical screening, medicinal chemistry, structural biology,
tumor biology, preclinical drug testing, and clinical trials, complemented by a
trans-Atlantic group of engaged patient representatives.
Methods
A bold plan will be pursued with a portfolio of projects that balance very high-risk
efforts with others nearing clinical implementation. We will focus on
drivers/targets in the following diseases: Ewing sarcoma, neuroblastoma, synovial
sarcoma, ependymoma and high-grade glioma. We will explore different
approaches to target these as yet undrugged paediatric drivers/dependencies, to
overcome resistance to available targeted inhibitors, and to improve the efficacy
and therapeutic window of CAR-T treatments.
How the results will be used
The aspiration of our team is to establish a sustainable platform for repeated
developmental cycles of paediatric-specific drug development for emerging targets
including a viable financial model to de-risk such developments for such rare
pediatric tumors to the direct benefit of our patients. Specifically, we anticipate
success through (i) delivering at least one optimised protein degrader for its
application in early-phase clinical trials, (ii) enabling the druggability of previously
“undruggable” targets, (iii) providing mechanistic insights into disease, novel
targets, and therapy resistance mechanisms and ways to tackle them.